Skeletal Muscle Engineering for the Craniofacial Region

PROJECT SUMMARY/ABSTRACT
Facial disfigurement can have devastating effects on one’s quality of life. Approximately 0.26 million Americans
per annum have reconstructive procedures, such as the use of tissue flaps, to correct congenital and acquired
craniofacial defects. Management of large volumetric craniofacial muscle tissue defects remains a challenge.
Up to one quarter of patients have repeat procedures due to flap failure, tissue rejection and limited availability
of tissue; and there remains a subset of patients for whom treatment completely fails resulting in continued
facial disfigurement, financial burden and challenges with societal integration. The ability to generate
craniofacial muscle tissue containing the patient’s own cells would provide a more predictable, life-changing
treatment for a serious problem. Previous work has demonstrated the importance of craniofacial muscle-
derived cells and scaffolds for engineering the craniofacial skeletal muscles.
The project proposes to engineer craniofacial muscle tissue by seeding 3-D printed biomimetic scaffolds with
porcine craniofacial muscle-derived cells. The goals are to (1) generate new knowledge on the use of
craniofacial muscle-derived cell populations for the formation of muscle tissue; (2) produce 3-D biomimetic
scaffolds to support craniofacial muscle development; (3) bioengineer craniofacial muscle tissue for
implantation. The vision is that permanent restoration of craniofacial soft tissue defects can be achieved by
implantation of precision-engineered autologous craniofacial skeletal muscle tissue. The hypothesis is that
successful craniofacial muscle tissue engineering applications will incorporate autologous craniofacial skeletal
muscle-derived cells, 3-D printed biomimetic scaffolds, application of mechanical load and insulin-like growth
factor 1 (IGF-1), a growth factor important for muscle cell proliferation and differentiation. The approach is to
enrich porcine craniofacial muscle-derived cell populations with muscle stem cells (satellite cells) responsible
for regeneration. The cells will be seeded into 3-D printed biomimetic scaffolds and subjected to load and IGF-
1 to improve regeneration and promote muscle fiber hypertrophy leading to a tissue suitable for implantation
into the craniofacial region. Aim 1 is to produce 3-D printed biomimetic scaffolds and assess response of an
enriched porcine craniofacial muscle-derived cell population within the scaffolds. Aim 2 is to determine
response of engineered porcine craniofacial skeletal muscle tissue to mechanical stimulation and IGF-1
delivered within customized bioreactors. Aim 3 is to determine the regenerative capability of engineered
porcine craniofacial skeletal muscle tissue in vitro and in vivo. This project ultimately aims to produce a
functional craniofacial tissue for restoration of craniofacial soft tissue defects through the combination of three
innovative elements: (1) craniofacial muscle-derived cell populations; (2) 3-D printed biomimetic scaffolds; (3)
application of external factors (mechanical load and IGF-1). The outcomes of the proposed research will
broadly impact skeletal muscle engineering applications for the entire human body.

Public health relevance
PROJECT NARRATIVE Facial disfigurement due to the loss of soft tissue is debilitating, and current therapies are limited because of tissue rejection and lack of suitable tissue. We propose to bioengineer craniofacial muscle tissue by using the subject’s own cells combined with innovative 3-D printing technologies and specialized bioreactors. This research has potential to advance our knowledge of muscle engineering applications, and develop novel and precise therapies to manage volumetric muscle tissue loss of the craniofacial region.